Targeting the Etiology of Diabetic Retinopathy

Project Summary
Diabetic retinopathy (DR) is clinically defined as a disease of the retinal microvasculature, and most research
on its pathogenesis to date has focused on the vasculature itself. Recent advances in multifocal ERG
demonstrate that neuro-retinal defects precede and even predict the development of DR. Thus, it is important
to investigate the molecular events that contribute to early loss of retinal adaptation to the metabolic
environment in diabetes.!Translation of mRNA is a major regulatory step in gene expression that is important
for controlling the expression of vascular endothelial growth factor (VEGF), as well as other critical growth
factors and cytokines in response to metabolic stress. Our central hypothesis is that a diabetes-induced shift
in the selection of mRNAs for translation within Müller glia results in loss of retinal homeostasis and the
eventual development of DR. Müller cells, the principal glial cell of the retina, are well recognized for the role
they play in the production of homeostatic and trophic factors that support both the vasculature and neuronal
layers of the retina. In diabetic patients, glial activation occurs prior to clinical manifestation of DR and likely
serves as an adaptive response to mitigate tissue damage. However, prolonged changes in Müller glial
protein expression become causative in the development of retinal complications. Specifically, Müller glia are
the principal source of increased retinal VEGF expression in diabetes, as conditional Muller cell specific
disruption of VEGF prevents elevated growth factor expression and reduces retinal vascular pathology. Our
laboratory has shown that diabetes-induced activation of the translational repressor 4E-BP1 promotes retinal
VEGF expression and the development of visual dysfunction in a model of type 1 diabetes. The objective
here is to address a fundamental gap in our understanding of the molecular events that produce early
changes in Müller cell specific protein expression. Using a newly developed RiboTag mouse model, wherein
expression of an epitope-tagged ribosomal subunit is directed to Müller glia, the proposed studies will provide
an unprecedented assessment of translationally active mRNAs in Müller glia within the intact retina. The
proposed studies are designed to characterize defects in the selection of specific mRNAs for translation in two
experimental models of diabetes: streptozotocin administration and high fat/high carbohydrate diet. In addition
to identifying regulatory mechanisms for specific mRNAs that contribute to glial dysfunction, the proposed
studies will also assess the development of retinal defects and visual deficits in the two experimental models
following Müller-specific genetic manipulation of the stress response protein REDD1 or protein O-
GlcNAcylation (i.e. two novel mechanisms for mediating specific changes in mRNA translation). The rationale
is that once the molecular defects in translational control mechanisms in retinal Müller cells are known, the
function/assembly of translation initiation factors can be manipulated pharmacologically, resulting in new
therapeutics that address dysregulated expression of multiple growth factors and cytokines including VEGF.
!

Public health relevance
Project Narrative A deficit in our understanding of the early molecular defects that underlie the development of diabetic retinopathy represents a critical barrier to the design and implementation of improved therapeutics. The studies proposed herein will identify translational control mechanisms that produce alterations in the expression of angiogenic, neurotrophic, and homeostatic factors in the retina of experimental models of type 1 diabetes and pre-diabetes. The results from the proposed studies are expected to identify new targets for intervention at the level of gene expression and thus lead to the development of innovative therapies to prevent diabetic retinopathy. !